Diversity Supplement to R01GM150698

Proximity labeling (PL) has emerged as a powerful approach for elucidating subcellular proteomes. In PL, a
catalyst is localized to a subcellular region of interest, where it tags nearby endogenous proteins; the tagged
proteins are then isolated and identified by mass spectrometry. Although PL catalysts have enabled numerous
biological discoveries, new PL catalysts are needed to enhance the sensitivity and specificity of spatially resolved
proteomic mapping. For example, genetically encoded enzyme catalysts (such as APEX and BioID) can be
conveniently targeted to cellular locations of interest, but they are limited in their chemical mechanisms of
tagging, which hampers control over the labeling radius (limiting specificity) and restricts which amino acids can
be tagged (limiting sensitivity). Recently, synthetic PL catalysts have enabled a greater diversity of chemical
labeling mechanisms, but new approaches are needed for selective activation of these catalysts in highly specific
subcellular regions of interest. My group has developed three classes of hybrid biological-abiotic PL catalysts,
offering improved sensitivity and specificity for spatially-resolved proteomic mapping. Each class of catalyst
offers complementary advantages, and the three aims will be pursued independently. In Aim 1, we have used
directed evolution to discover heme peroxidase enzymes capable of generating highly reactive radicals, which
exhibit a shorter diffusion radius compared to the widely used APEX/biotin phenol methodology, allowing for
enhanced spatial resolution. Additionally, we are developing peroxidase-based PL methodologies to label
chemically diverse amino acids, in contrast to the APEX approach that almost exclusively labels tyrosines. This
ability to react with more amino acids will enhance sensitivity for detecting proximal proteins. In Aim 2, we have
developed hybrid DNA-synthetic PL catalysts that become activated only in highly specific subcellular locations.
We are applying these switchable catalysts for activation of PL selectively at protein–protein interactions (PPIs)
on the surface of cancer cells, and we will extend this approach for activation at intercellular PPIs in neuronal
synapses. In Aim 3, we have developed hybrid DNA-synthetic catalysts that tag proteins through contact-
dependent mechanisms, instead of generating diffusible reactive species. We will attach these contact-
dependent catalysts to DNA nano-rod structures with tunable lengths and rigidities, enabling precise control over
the labeling radius in the range of ~1–50 nm. For all three research areas, we are applying the novel PL catalysts
for proteomic mapping in living mammalian cells, in collaboration with Prof. Lloyd Smith, an expert in high-
resolution biomolecular mass spectrometry. Additionally, we are collaborating with Prof. Edwin Chapman to
employ these PL tools in cultured neurons to benchmark their performance against existing tools. Throughout
the next five years, my laboratory will continue to develop new mechanisms for PL using hybrid abiotic-biological
catalysts. I envision that these tools will be employed not only in my laboratory, but also in the broader
community, to elucidate novel protein functions in a variety of biological contexts.

Public health relevance
Martell project narrative Technologies that enable the identification of which proteins reside in specific locations inside cells are critical for elucidating biological processes and disease states, including neurodegeneration, pathogenic infection, and cancer. One promising strategy to achieve this goal is proximity labeling (PL), but in order to enhance the sensitivity and specificity of proximal protein detection, improved PL catalysts are needed. We propose that hybrid biological-abiotic PL catalysts developed in our laboratory will enhance both sensitivity and specificity in spatially- resolved proteomic mapping, and we are employing these catalysts in neurons to benchmark their performance against existing methods and establish their broad utility as research tools.